Development of Gene-Silencing Therapeutics for Pseudomonas aeruginosa

PROJECT SUMMARY/ABSTRACT
Gram-negative pathogens are becoming increasingly resistant to many antimicrobials. Furthermore, the pipeline
for new antibiotics is small and new therapies are urgently needed. This can be especially problematic in patients
who suffer from chronic infections or are immunocompromised. Multidrug-resistant Pseudomonas aeruginosa
has been identified by the Centers for Disease Control and Prevention as a serious threat. P. aeruginosa causes
healthcare associated infections in a variety of clinical settings and hosts, but is particularly devastating in
patients with cystic fibrosis (CF). We have been interested in using antisense molecules called PPMOs as
potential therapeutics in these infections. These molecules block messenger RNA and prevent the formation of
the target protein. We have demonstrated that PPMOs can be used to target genes that are essential for
Pseudomonas to grow, such as acpP, lpxC or rpsJ. We showed that blocking these proteins are essential for
Pseudomonas to grow in vitro. We also showed that these PPMOs improve survival in mice that were infected
with Pseudomonas. For this project, we propose to further characterize our lead PPMOs in a larger collection of
Pseudomonas isolates, both antibiotic-sensitive and multidrug-resistant. In addition, efficacy studies will be
performed in both models of pneumonia and bloodstream infection. This process will result in 2-4 PPMOs that
will undergo further pre-clinical testing including toxicity, resistance, pharmacodynamic and pharmacokinetic
studies. By the end of the proposed project, a lead PPMO will have undergone the needed pre-clinical testing
for IND submission to the FDA. This innovative approach to developing novel antibiotics, particularly for P.
aeruginosa, could help expand the increasingly shrinking classes of effective antibiotics that are used to treat
these severe, life-threatening infections.

Public health relevance
Project Narrative Antibiotic resistance among gram-negative bacterial pathogens is becoming increasingly frequent. This is particularly true in patients who suffer from chronic infections or are immunocompromised, such as in those with cystic fibrosis. One pathogen that causes significant morbidity and mortality is Pseudomonas aeruginosa. We have developed antisense molecules that effectively kill this pathogen, including in drug-resistant isolates. We will further characterize our lead antisense molecules and nominate an ultimate lead for IND submission.